Social Determinants and Epigenetic Mediators of Hypertension in the Future of Families and Child Wellbeing Study

Project Summary
Cardiovascular diseases (CVD) such as myocardial infarction and stroke are the leading causes of death in the
United States (US), and widespread disparities in CVD burden exist across socioeconomic, racial, and ethnic
groups. High blood pressure (BP), or hypertension (HTN), is the most prevalent risk factor for CVD.
Importantly, higher BP in young adulthood, even within the clinically normal range, tracks with cumulative
lifetime exposure to elevated BP levels, leading to earlier development of clinical HTN and significantly greater
CVD risk, despite use of optimal antihypertensive therapy later in life. Primordial prevention of BP elevation is
therefore needed to reduce HTN-related morbidity. Social determinants of health (SDOH) could contribute to
observed disparities in uncontrolled BP and increasing proportions of HTN among US adults. Notably, early life
SDOH have been associated with epigenetic changes in DNA methylation (DNAm), potentially accelerating
HTN and CVD development, but limited work has considered long-term relationships between early life SDOH,
epigenetic mechanisms, and CVD risk factors. Our overarching hypothesis is that early life SDOH are
associated with young adult BP levels, and that DNAm statistically mediates these associations. To examine
this hypothesis, we will pursue the following Specific Aims: 1) investigate early life SDOH and young adult BP
associations, 2) investigate temporal associations between DNAm and young adult BP, evaluating DNAm as a
mediator of SDOH-BP associations, and 3) replication to examine the durability of these associations. We will
primarily utilize the Future of Families and Child Wellbeing Study (FFCWS), a diverse prospective cohort study
collecting phenotype, genotype, epigenetic, and parental data in children from birth to young adulthood. In Aim
1, multi-trajectory modeling and latent class analysis will assess SDOH trajectories and cumulative exposures.
Aim 2 will involve epigenome-wide association and mixed-effect models to examine repeated longitudinal
measures of SDOH and DNAm. Standard and high-dimensional mediation analyses can quantify DNAm
effects within SDOH-BP associations. Aim 3 replication of FFCWS association and mediation analyses will be
performed in the diverse community-based CARDIA cohort, which has collected extensive SDOH, phenotype,
genotype, and epigenetic data in participants from young adulthood through middle age. This work will provide
longitudinal insight into the complex interplay between SDOH, epigenetics, and BP, deepening our
understanding of primordial risk factor prevention and tailored interventions to prevent HTN. If awarded, this
fellowship will allow me to contribute novel research to the SDOH and CVD fields, gain competency in the
development and application of biomedical informatics and analytical methods, and improve my writing and
presentation skills, while learning from a sponsor team with extensive subject matter and mentorship expertise.
Completion of this project and training will prepare me for my career goal of becoming an independent
academic investigator, using data science and informatics tools to research SDOH and improve public health.

Public health relevance
Project Narrative Social determinants of health (SDOH) in childhood may contribute to increased blood pressure in young adults, leading to earlier development of hypertension and cardiovascular disease risk later in life that cannot be fully mitigated by optimal blood pressure reduction. Adverse early life SDOH have also been linked to epigenetic alterations in DNA methylation, therefore we hypothesize that early life SDOH are associated with young adult blood pressure, and that DNA methylation statistically mediates these associations. The proposed research, utilizing high-quality prospectively-collected longitudinal birth cohort data from >1400 participants and their parents in the Future of Families and Child Wellbeing study, will provide long-term insight into the complex interplay between SDOH factors, epigenetics, and blood pressure, adding to our understanding of primordial risk factor prevention in public health as well as tailored interventions to prevent hypertension.